Breast Cancer Brain Metastasis Therapy by Focused Ultrasound-Guided Control of HER2 CAR T cells

Project Summary
HER2-targeted therapies are promising treatment options for metastatic breast cancer and have improved the
median overall survival. However, breast cancer brain metastasis (BCBM), which is observed in up to 50% of
HER2-positive breast cancer patients, continues to be a clinical challenge with most patients surviving less than
2 years following CNS involvement. These dismal outcomes underscore the need for new and more effective
treatments for BCBM. Chimeric Antigen Receptor (CAR) T cell therapy has led to durable responses in patients
with certain types of blood cancers. However, the treatment of brain tumors, such as BCBM, involves a unique
set of challenges, including limited infiltration of CAR T cells, heterogenous expression of target CAR antigens,
and high systemic toxicity. Although direct intracranial administration of CAR T cells has resulted in anti-tumor
responses in a few patients with relatively low systemic toxicity, BCBM is multifocal and requires repeat
treatments, which pose significant challenges to effective delivery. Moreover, in recent clinical trials,
heterogeneous antigen expression led to relapse from the outgrowth of antigen-negative tumor cells. Therefore,
new strategies that can concurrently increase CAR T cell infiltration, combat tumor heterogeneity, and limit off
target toxicity are necessary to address the critical and unmet need to treat BCBM. Recently advances in
Magnetic Resonance guided Focused Ultrasound (MRgFUS) technology and CAR T cell engineering are
uniquely suited to advance CAR T cell therapy for difficult-to-treat BCBM. Closed-loop control of MRgFUS
enables spatially localized and noninvasive application of mild hyperthermia (41.5 ± 0.5 oC) in the brain across
an intact skull that can transiently increase perfusion and vessel permeability in brain tumors. Preliminary studies
indicate that FUS-induced hyperthermia also increases trafficking of CAR T cells to brain tumors. In
complementary studies, engineered CAR T cells that respond to mild hyperthermia (40–42 oC) by producing a
bi-specific T cell engager (BiTE) that targets CD3 and natural killer group 2 member D ligands (NKG2DL) has
been shown to potentiate anti-tumor activity and mitigate antigen escape. By merging these synergistic advances
in image-guided therapy and CAR T cell engineering, the proposal objective seeks to apply thermal targeting of
brain tumors by MRgFUS to enhance therapeutic trafficking of CAR T cells and spatially control the intratumoral
production of BiTEs to potentiate anti-tumor responses against BCBM. Preclinical studies will focus on HER2+
BCBM using both syngeneic and human HER2 (hHER2) transgenic mouse models. The proposed grant will
refine, integrate, and test using clinically relevant models two exciting technologies that, if successful, can offer
desperately needed new treatment strategies to patients with BCBM.

Public health relevance
Project Narrative Breast cancer brain metastasis is observed in up to 50% of HER2-positive breast cancer patients and patients survive less than 2 years following CNS involvement. CAR T cells are a promising new treatment but typically results in poor responses against solid tumors. This proposal seeks to apply thermal targeting by Magnetic Resonance guided Focused Ultrasound to increase anti-HER2 CAR T cell delivery and potentiate therapy against breast cancer brain metastasis.